Research Program Administration

RESEARCH PROGRAM ADMINISTRATION (RPA) CORE
Summary
The overarching goal of FAMU RCMI Center application (2019-2024) is to establish an interdisciplinary Center
addressing minority health and health disparities. The Center will focus on efforts to pursue excellence in
health disparities basic and behavioral research, training “next generation” minority biomedical and behavioral
scientists and to support community partnerships that reduce racial health disparities. The overall goal of the
Research Program Administration (RPA) Core is to manage and coordinate the entire range of the Center's
activities, monitor its progress, and confirm that all the component's plans are implemented. The key RPA
components of the core consist of the: PI/PD, Co-PD, Core Leaders, Research Projects PIs, External Advisory
Committee (EAC), Internal Advisory Committee (IAC) and External Program Evaluator. These units will work
as one team to implement the development of concepts, directions, monitoring, and review of research
activities; and oversee the implementation of program initiatives. A critical function of the RPA is to implement
and manage the Career Enhancement Program (CEP) which will: 1) Provide workshops and training
programs. 2) Support faculty and staff attendance at national conferences, workshops, and training in minority
health and health disparities. 3) Provide scientific seminars. 4) Support the RCMI Research Collaboration
Program. 5) Leveraging RCMI Research Coordination Network (RRCN) and the National Research Mentoring
program (NRMN) for career enhancement and training. The RPA will work with the external program evaluator
to evaluate the FAMU RCMI Center proficiency, progress, and outcomes for defined specific aims and goals.
In the evaluation plan, inputting parameters will be used to reach data-driven decisions and steer the future
direction of the program, optimizing the efficiency, effectiveness, and success. Services provided by RPA will
ensure investigators advancing their area of research experiences and expertise to focus on diseases that
affect minority groups and to reduce health disparities.
1